Geographically-Explicit Ecological Momentary Assessment Protocol to Assess the Linkages Between Intersectional Discrimination and CVD Risk Among Sexual and Gender Minorities

Young adulthood is increasingly marked by the early onset of chronic conditions, such
as systemic inflammation, compared with previous generations. A primary contributor to
this trend is engagement in harmful cardiometabolic health behaviors (CHB), including
physical inactivity, dysregulated sleep, smoking, and alcohol use. Stress is a key driver
of these behaviors, yet research has not fully captured how stress shapes CHB in ways
that reflect the lived experiences of young adults. To address this gap, we propose an
innovative approach that integrates geographically explicit ecological momentary
assessment (GEMA) with qualitative mapping to examine the contextual features of
stress, protective social factors, and CHB among young adults. Qualitative mapping
combines GPS and EMA activity data with in-depth interviews, allowing participants to
describe their thoughts, feelings, and experiences within the mapped locations. This
method is critically important because exposures to stress vary by geographic space and
are appraised differently depending on contextual factors such as purpose of the space
(for example home, work, or school), perceived safety, and time spent there. Our
overarching goal is to elucidate the complex relationships between environmental and
interpersonal experiences of stress and CHB among diverse young adults. Specifically,
this study will (1) examine how daily experiences of stress and CHB differ across levels
of structural inequality, measured through integrated GPS and census data, (2) assess
how protective social factors such as social cohesion and community relationships buffer
the negative impact of stress on CHB, and (3) explore context-specific risks and
protective factors associated with CHB across racial and ethnic groups of young adults
using the GEMA methodology. By capturing stress in real time and situating these
experiences within their geographic and social contexts, this study offers a highly
innovative and ecologically valid approach. Findings will provide critical insights to inform
the development of tailored CHB prevention interventions for diverse young adults,
including future Just in Time adaptive interventions designed to reduce health
disparities.

Public health relevance
Stress during young adulthood contributes to harmful health behaviors such as poor sleep, smoking, alcohol use, and physical inactivity, which increase the risk of early chronic disease. This project uses innovative real-time methods to understand how stress is experienced in everyday environments and how social supports can reduce its harmful effects. Findings will guide the development of tailored prevention strategies to improve the health of young adults and reduce long-term cardiometabolic disparities.